Dynamic Pattern Formation in the Cell Cortex

Project Summary
All eukaryotic cells share the ability to heal themselves and to divide; these capacities are
essential for life and, when deficient, result in a variety of human diseases. While both
processes occur in response to very different stimuli—damage in the case of healing, anaphase
onset in the case of cell division—the same core players are employed: Rho GTPases and their
ultimate targets, the components of the actomyosin cytoskeleton. In keeping with the fact that
the stimuli are different, the regulators that control Rho GTPases in cell repair and cell division
differ considerably. However, we have discovered that in both cell repair and cell division, the
regulators impact the Rho GTPases in a fashion that produces GTPase activity waves. For cell
repair, two complementary, concentric waves, one of Cdc42 activity and one of Rho activity,
form around wounds and close inward, with a ring of actomyosin closing over the wound in their
wake. For cytokinesis, randomly moving waves of Rho activity are initially found throughout the
cell cortex, but become focused at the cell equator by the mitotic spindle. Once confined to the
equator, the waves direct the assembly of the actomyosin-based cytokinetic apparatus, which
follows the waves inward and pinches the cell in half.
Here we propose experiments designed to determine how the waves arise, how they assume
their characteristic forms, and how they are interpreted by the cell cortex to build the
actomyosin-based structures needed for healing and cell division. The proposed work will
provide fundamental new insights into cell repair and cell division. Given the medical
importance of these processes, the proposed work will likewise benefit efforts to improve human
health.

Public health relevance
Project Narrative Understanding how cells heal themselves and how they divide is essential to treating diseases ranging from muscular dystrophies to cancer. The proposed work will yield direct insight into cell healing and cell division, thus providing opportunities to develop treatments that ameliorate these diseases.